Dynamic probes of endogenous protein aggregation and cell signaling

Project
Summary/Abstract:
The dynamics of cell signals are instructive features that guide cell and tissue behavior. Yet, many important
pathways, like the Wnt/-catenin pathway, lack probes to observe and dissect endogenous signal dynamics
with precision in space and in time. The overall goal of this proposal is to develop novel molecular probes that
can visualize and perturb endogenous signal dynamics, with a focus on the Wnt/-catenin pathway. Our
proposal is divided into two projects. In the first project, we will develop a novel fluorescent biosensor to enable
direct visualization of Wnt signal dynamics. Existing Wnt reporters can be dim and require genomic
engineering of the target cell, act on slow transcriptional timescales that can obscure the upstream pathway
dynamics, and provide no spatial information about the input Wnt signal. Because Wnt stimulation requires the
aggregation of pathway co-receptor LRP6, observation of LRP6 oligomerization could provide a
spatiotemporally resolved readout of pathway activity. We thus envision a new class of biosensor that allows
observation of the aggregation of intracellular proteins. Our reporter must meet two important design criteria.
First, it must report on endogenous protein clustering to avoid overexpression of signaling proteins or genomic
modifications. Second, because physiological protein aggregates are small and often below the diffraction limit
of visible light, our reporter must “visually amplify” endogenous clusters such that they are visible by
conventional microscopy. We describe plans to develop, characterize, and apply such a reporter, called
CluMPS. CluMPS visually magnifies small endogenous protein clusters through principles of protein phase
separation. Using both experiments and simulations, we will characterize the ability of CluMPS to detect and
amplify intracellular protein aggregates, using optogenetic clustering of GFP as a model analyte. We will then
apply CluMPS to detect clusters of endogenous proteins known to form physiological aggregates. Finally, we
will apply CluMPS to detect the clustering of endogenous Wnt receptor LRP6 in response to cellular Wnt
stimulation, and we will validate LRP6-CluMPS activity in cell, tissue, and developmental models. The
modularity of CluMPS will allow its adaptation to generate sensors of diverse signaling pathways and cell
states. In the second project, we will engineer the first optogenetic tools to allow inhibition of endogenous
signaling pathways with spatiotemporal precision. We will target inhibition of both Wnt/-catenin signaling and,
separately, Ras-Erk signaling. We will validate successful pathway inhibition in the context of cell culture
models of cancer and patterning of in vitro intestinal organoids. Notably, all of our probes will be designed in a
modular fashion and thus could be readily modified to observe or inhibit diverse targets of interest. Success in
our work will result in a suite of new tools to observe, perturb, and understand the fundamental biochemical
processes that underlie normal physiology and its breakdown in disease, in close alignment with the central
mission of NIGMS.

Public health relevance
Project Narrative We will develop a new class of molecular probes to visualize and control the dynamic signals that regulate all cell and tissue function. Because our tools are modular, our designs will be widely applicable to study diverse physiological processes, as well as their breakdown in disease. Importantly, our probes could in the future be adapted as sensors of several disease states including neurodegeneration and certain cancers, and thus will present powerful opportunities to study and ultimately treat a broad range of human disease.